From Locus to Function: Role of ZEB2 in Human Risk of Coronary Artery Disease

ABSTRACT
Coronary artery disease (CAD) remains the leading cause of death in the U.S. and worldwide. Identifying
genetic risk factors and uncovering the underlying biological processes will lead to the development of much
needed new avenues for therapies. Decades of genetics research, especially genome wide association studies
(GWAS), have led to the discovery of numerous genetic loci associated with an increased risk for CAD.
However, the majority of these loci lie in non-protein-coding regions. Efforts are needed to identify causal
genes associated with these loci and the underlying cellular processes and signaling pathways. Recent
advances in epigenomic and transcriptomic profiling at unprecedented depth and resolution, along with
targeted genome/epigenome editing provide new opportunities to identify specific genes and cellular
mechanisms in CAD.
This K08 career development award is designed to launch the principal investigator’s career as an
independent physician scientist that utilizes complementary computational and molecular approaches to
discover the mechanisms that underlies human genetic risk to cardiovascular disease and translates these
findings into treatment. The principal investigator ‘s Mentor (Thomas Quertermous) is a world leader in
mechanistic studies of genetic risk of atherosclerosis. The proposed training is further supplemented by an
advisory committee of leaders in computational biology, genetics, and single-cell multi-omic analysis, including
Michael Snyder, Erik Ingelsson, William Greenleef, and Siddhartha Jaiswal, along with formal didactic courses
at Stanford University and Cold Spring Harbor.
Funded by an F32, the principle investigator used a combination of in vitro and in vivo models of
atherosclerosis and linked the non-coding CAD risk loci at 2q22 to ZEB2, a transcriptional repressor with a
critical role in cell-state transitions. ZEB2 appears to be specifically up-regulated in phenotypically modulated
smooth muscle cells (SMC) in atherosclerotic lesions, and modulates their cell-fate decisions. The proposed
study will: (1) identify the causal regulatory element(s) responsible for the CAD-Risk-associated region at 2q22;
(2) reveal the molecular mechanisms by which ZEB2 affects phenotypic modulation of SMC; (3) determine the
cellular mechanism by which perturbation of smooth muscle cell Zeb2 expression modulates atherosclerotic
lesions in vivo. The result of this study will elucidate new regulatory mechanisms that modulate atherosclerosis
biology. Additionally, the principle investigator will gain the training needed to transition into an independent
physician scientist focusing on translating genetic findings of human cardiovascular disease into specific
mechanisms and novel therapies.

Public health relevance
PROJECT NARRATIVE Many genetic research studies have shown that a relatively obscure region on chromosome 2 is highly associated with human coronary artery disease, but how this region of the genome causes heart disease is unknown. This proposed study examines how this obscure region is linked with a gene associated with cancer, ZEB2, and shows how this gene can influence a person’s chance of a heart attack using a combination of state of the art tools including genome editing, cell and animal models, and genetic data at the level of single individual cells.